Regulatory mechanisms of rare non-coding variation in neurodegeneration-associated loci

Abstract
The goal of this NIH Pathway to Independence award is to provide Dr. J. Nicholas (Nick) Cochran with
a comprehensive training program to prepare him to be a leading independent investigator who uses genomic
approaches to study neurodegenerative disease. We propose one year of training in functional genomics,
advanced statistics, and advanced data science to complement over ten years of training that Dr. Cochran has
received to date in neuroscience and genomics. Genome sequencing studies continue to provide new
statistical associations with disease, but to date non-coding variation has been largely disregarded. A critical
barrier to incorporating rare non-coding variation into burden analyses and to further studying the effects of
those variants on transcriptional complexes or disease-related cell biology has historically been a lack of an
ability to properly categorize the effect of non-coding variants and establish them as disease-associated. The
PI has put forward one approach to address this barrier using computational filtering in a recent study, and the
aims here will allow for further mechanistic refinement of approaches to assess the functional consequences of
rare non-coding variation for neurodegenerative diseases. In addition to allowing for discovery of more gene-
disease associations, the location of disease-associated non-coding variants will inform on the biology of how
the target genes are regulated (resultantly providing insight into disease etiology), and could even provide
support for new therapeutic avenues for consideration by providing evidence for the three dimensional protein
complexes controlling expression of disease associated genes, which, if understood well enough, may be
druggable. This would have broad applicability for any gene-disease association. However, given the focus of
this proposal, the PI specifically proposes (1) experiments to understand regulation and rare variant influences
on MAPT (which codes for tau, a critical protein in many neurodegenerative diseases), (2) experiments to
provide true positive and true negative training sets of rare non-coding variation statistically associated with
neurodegenerative diseases by case-control studies by performing functional assays on these variants, and (3)
experiments to elucidate rare non-coding variation influences on disease associated stimuli, with amyloid beta
treatment as a proof-of-principle. The mentor and co-mentor are leaders in the genetics and genomics field, Dr.
Richard Myers (HudsonAlpha) and Dr. Gregory Cooper (HudsonAlpha). Dr. Cochran has also assembled a
committee of leaders in the neurodegeneration field including Dr. Kenneth Kosik (UCSB), Dr. Erik Roberson
(UAB), and Dr. Jennifer Yokoyama (UCSF), all of whom employ genetics and genomics approaches in their
work. The mentored phase will take place at the HudsonAlpha Institute for Biotechnology, a non-profit research
and teaching institute with an ideal environment and infrastructure to support this functional genomics project.
In summary, the proposed studies will allow for Dr. Cochran to hone his functional genomics skillset as he
transitions into an independent investigator role.

Public health relevance
Project Narrative The major outcome of this project will be a scientist with the necessary research, mentoring, teaching, and career development training to run an independent research program in neuroscience and genomics. The research proposed will apply new strategies to better understand the contribution of rare non-coding genetic variation to disease risk. In the long run, this will allow for better assessment of risk for neurodegenerative disease based on genetic profile and will also contributing to basic science knowledge of how neurodegeneration-associated genes are regulated.